Defining gene-by-environment interactions using multiplex single-cell genomics

PROJECT SUMMARY
The proposed research program aims to develop systems for the multiplex assessment of the effect of genetic
perturbation on the response of cells to exogenous and endogenous exposures at the resolution of individual
cells
. Specifically, we will develop a flexible and scalable in vitro platform for high-throughput single-cell gene-
by-environment interaction screens that couples CRISPR-based single-cell pooled genetic screens to a “nuclear
hashing”-based sample multiplexing strategy and a single-cell genomic readout. This platform will allow for the
simultaneous molecular description of 1,000s-10,000s of unique conditions (i.e. gene and exposure
combinations) at the resolution of individual cell types and cell states. In addition, we propose to develop a set
of tools based on heterologous viral receptor expression for the in situ and cell-type specific delivery of CRISPR-
based genetic perturbations in a manner compatible with single-cell RNA-seq. We highlight the versatility and
generalizability of our approach across three applications of our technologies that aim to define gene-by-
environment interactions in neurobiological disease. We propose to dissect the genetic interactions between
mutations associated with Alzheimer’s disease and the transcriptional response of neural cell types to oxidative
stress and peptide aggregates; to characterize the transcriptional effects associated with cell-type specific
modulation of genetic modifier activity in response to mutations in genes that cause epilepsy disorder and; to
determine how genes that are commonly mutated in brain cancer alter the response of murine tumors to
therapies in vivo. Our goal is to arrive at clinically actionable molecular descriptions of how individual genes
contribute to the response of individuals to exposure.

Public health relevance
PROJECT NARRATIVE The risk and severity of disease associated with environmental and endogenous exposures can vary greatly depending on the unique genetic makeup of an individual. The large number of possible genetic and environment combinations limits our ability to identify these interactions despite their potential to inform strategies for disease prevention and therapeutic intervention. I propose to develop high-throughput methods that overlay genetic and environmental perturbations to systematically identify these gene-by-environment interactions as well as pinpoint the specific cell types responsible for the response.